Society for Birth Defects Research and Prevention 2020-2024 Annual Meetings

Project Summary Abstract
The Society for Birth Defects Research and Prevention (BDRP), established in 1960 as the Teratology Society,
will hold its 60th Annual Meeting at the Charleston Marriot, in Charleston, South Carolina—June 27–July 1, 2020.
The scientific program covers a wide range of cutting-edge topics in birth defects research and disorders of
developmental origin. The 2020 program will highlight the current insights on neurodevelopmental outcomes or
other childhood health disparities following exposure to water fluoridation or methyl mercury; the impact of
prenatal opioid exposure and the clinical management of neonatal opioid withdrawal syndrome; use of data from
experimental animal studies in reproductive counseling; the consequences of obesity and metabolic disorders
on child health and development; current methods used to assess and model early childhood exposure to inform
risk assessments; and the role of the maternal immune system in the establishment, maintenance, and
completion of a healthy pregnancy. Other topics will focus on inclusion of pregnant women in clinical trials;
current breakthroughs and ethical challenges associated with CRISPR/Cas9 technology; and the emerging
science of human embryogenesis at single-cell resolution. Meeting attendees will also have the opportunity to
learn about the development of the immune system and the advances in juvenile toxicology. The keynote
address will explore how advances in prenatal genomic medicine are providing new insights into maternal,
placental, and fetal biology. Meeting attendees historically come from diverse professional backgrounds
including basic and clinical scientists from the academic, industrial, and government research sectors. The
Annual Meeting provides a unique forum where basic, clinical, and epidemiologic researchers come together to
share progress toward a common understanding of the causes and mechanisms of birth defects and
developmental disorders, and to translate these discoveries into clinical practice. It is also an opportunity to
promote and express our scientific diversity as a Society of fellow clinicians, scientists and science policy
regulators from academic, industrial, and government sectors. This diversity allows the Society to promote
translational research in approaching problems from basic science to clinical outcomes by bringing together
these scientists and clinicians in its unique annual meeting programs. In this application, we are requesting funds
to defray the scientific session audiovisual expenses for 2020–2024 BDRP Annual Meetings.

Public health relevance
Project Narrative For 59 years, the Society for Birth Defects Research and Prevention (BDPR), established in 1960 as the Teratology Society, has promoted basic and clinical research to understand the causes and mechanisms of birth defects, the potential effects of drug, chemical, infectious or other exposures on the developing embryo/fetus, improve reproductive health, understand developmental origins of adult disease, and translate these discoveries into clinical practice and regulatory application. The Annual Meeting provides a forum for scientists, clinicians, and science policy regulators from academic, industrial, and government sectors to present cutting-edge research, exchange ideas and information, and engage in discussions among established experts in the field, new researchers, and students. The goals of BDRP align with the US FDA’s mission to protect the public health, as evidenced by the theme of the 2020 Annual Meeting, Honoring Teratology’s Roots, Growing a Healthier Future.